Development of ultra-efficient antibodies for single cell mapping applications

PROJECT SUMMARY
Histone post-translational modifications (PTMs) are some of the most widely studied epigenomic factors,
and alterations in histone PTM abundance / distribution have been implicated in numerous disease etiologies.
Epigenomic mapping of histone PTMs in limited cell populations or single cells (SCs) would provide the
opportunity to study the epigenetic landscape of rare and heterogenous cell populations and be highly enabling
for drug discovery research. The recent development of the antibody-mediated genomic mapping approach
CUT&Tag (Cleavage Under Targets and Tagmentation) permits the study of select, abundant histone PTMs
using very few cells and even SCs. Despite this progress, ultra-low input and SC CUT&Tag assays still present
a unique challenge, and have not yet been successfully applied to many challenging targets, such as less
abundant histone PTMs. Indeed, to maximize data yield per cell, ultra-low input and SC CUT&Tag assays require
antibodies to exhibit high on-target epitope binding with minimal off-target binding, which most commercial
antibodies do not offer. We envision a new class of “SC-grade” antibodies that deliver ultra-efficient histone PTM
binding for dramatically increased CUT&Tag assay sensitivity, improving reliability and providing access to new
targets that are currently intractable. Here, EpiCypher will leverage a novel antibody development pipeline to
generate ultra-efficient, “SC-grade” antibodies to unlock the potential of genomic mapping technology for next-
generation ultra-low input / SC applications. Unlike traditional antibody development pipelines that use histone
peptides for screening, a central innovation of our strategy is the implementation of recombinant modified
designer nucleosome technology during antibody development. In Phase I equivalent studies, we used our novel
approach to select and validate ultra-efficient antibodies for two key histone PTM targets (H3K4me1 and
H3K4me3), generating antibodies that exhibit a >5-10x increase in nucleosome capture efficiency vs. current
best-in-class antibodies. Importantly, these ultra-efficient antibodies generated significantly greater signal-to-
noise in genomic mapping assays that employ low cell inputs, demonstrating strong proof-of-concept for our
approach. In Phase II, we will leverage this validated antibody development pipeline to develop a suite of ultra-
efficient antibodies and use these reagents to develop low input and SC CUT&Tag assays for breakthrough
immunology research. Toward this goal, we will first develop and screen antibodies for high-value histone PTM
targets (Aim 1). We will then scale up production and rigorously validate antibody lots in CUT&Tag assays using
both low input and SC workflows (Aim 2). Finally, we will test the application of our next-generation ultra-efficient
antibodies to enable cutting-edge immunological research and provide our antibodies and validated protocols to
leading epigenetics laboratories for beta testing (Aim 3). This research project will result in the development of
a new class of histone PTM antibodies that will be used to increase the utility of CUT&Tag assays for
breakthrough chromatin research and drug discovery.

Public health relevance
PROJECT NARRATIVE Histone post-translational modifications (PTMs) are some of the most widely studied epigenomic factors, and alterations in histone PTM abundance and distribution have been implicated in numerous disease etiologies. However, efforts to map histone PTMs in limited samples and single cells, such as rare primary immune cells and clinical samples, have been hindered by the lack of high-quality antibodies. To meet this need, EpiCypher is developing a novel antibody development pipeline to create ultra-efficiency antibodies that enable low and single cell genomic mapping assays.